Genetic determinants of interbacterial competition during host colonization

Project Summary
The biological functions of microbiomes are critical to human health. Perturbations of
these microbiomes can lead to damaging consequences including improper host
development and increased susceptibility to infectious disease. Competitive interactions
among microbial populations are predicted to influence the structure and function of
microbiomes, yet the molecular mechanisms underlying these interactions remain
unclear. Understanding microbiome dynamics is therefore critical to predicting and
mitigating dysbiosis and disease risk in humans. Type VI secretion systems (T6SSs) are
a conserved protein export mechanism found in both pathogenic and beneficial human-
associated bacteria. T6SSs act as molecular syringes to translocate toxic effector
proteins directly into competitor cells, resulting in inhibition or death. Given their role in
interbacterial competition, T6SSs are capable of structuring microbiome communities
within a host-associated niche. The goal of this proposal is to understand how T6SS-
mediated interactions shape host-associated microbiomes. The results of this work will
facilitate the development of strategies to improve host health. Recent findings using the
squid light organ as a model system indicate that bacteria can use their T6SS to
compete for a limited number of colonization sites in the host. The proposed work will
determine the molecular mechanisms underlying T6SS-mediated killing among co-
colonizing bacteria, and determine the spatial and temporal dynamics of these
competitive interactions in the host, and its effect on structuring the resulting
microbiome.

Public health relevance
Project Narrative We use a natural host colonization model system to study how competitive interactions between bacterial populations impact which populations can infect and persist inside a host. We found that bacterial colonizers use a type VI secretion system (T6SS) to kill competing strains for access to host colonization sites. We will determine how these bacteria target other cells for killing, as well as the extent to which competition influences the spatial arrangements of members comprising a natural host-associated microbiome.